Converging molecular mechanisms in axon degeneration and astrocyte morphogenesis

SUMMARY
Astrocytes are one of the major glial subtypes of the central nervous system (CNS), evolutionarily conserved
from Drosophila to humans with regard to their morphology, molecular composition, and function. Although
their morphological complexity is thought to be essential for astrocytes to perform their myriad roles in the CNS
by physically contacting and interacting with diverse neural structures, including synapses and the vasculature,
we only know of a handful of pathways that critically regulate astrocyte morphology. From an unbiased,
forward genetic screen in Drosophila, we surprisingly identified dSarm and dWnk/Fray, both of which have
been implicated in axon degeneration, as potential new regulators of astrocyte morphology. Preliminary
findings in Drosophila show that dSarm/Sarm1 and dWnk/WNK work synergistically to regulate not only axon
degeneration but also astrocyte morphology. Here, we propose to leverage the larval zebrafish system to ask
whether the role of Sarm1 and WNK in regulating astrocyte development is evolutionarily conserved. In the
axon degeneration pathway, NAD+ depletion is thought to be upstream of dSarm/Sarm1 and dWnk/WNK
activation, and Axundead (Axed) to be downstream. Whereas the importance of NAD+ depletion upstream of
dSarm/Sarm1 and dWnk/WNK has been shown across species, the functional ortholog of Axed is unknown in
vertebrates. We therefore propose to determine if and how these known axon degeneration pathways up- and
downstream of dSarm/Sarm1 and dWnk/WNK also function in vertebrate astrocytes. By harnessing the
pharmacological and genetic toolkits available in larval zebrafish, we will interrogate the involvement of the
NAD+ biosynthetic pathway in controlling process dynamics and morphology of astrocytes in vivo. We will
additionally perform a targeted reverse genetic screen to identify the functional vertebrate ortholog of Axed in
mediating Sarm1/WNK effects on astrocyte morphology. Together, this study will define new roles for key
molecules in axon degeneration in the regulation of astrocyte morphogenesis and further our understanding of
the Sarm1 signaling pathway in vivo.

Public health relevance
PROJECT NARRATIVE The highly elaborate morphology of astrocytes is evolutionarily conserved and tied to their many functions in the CNS, though our understanding of how this morphology is regulated is incomplete. Here, we propose to investigate how astrocyte morphology is regulated by the Sarm1-WNK-NAD+-Axed signaling axis, a canonical molecular pathway most known for its involvement in axon degeneration. By using pharmacology, genetics, and in vivo imaging in the larval zebrafish, our work will uncover new molecules crucial for astrocyte morphogenesis and provide new insights into the Sarm1 signaling pathway.